Regenerative peptide therapy to accelerate pressure ulcer healing

Abstract
Adrenomedullin (ADM) and CGRP family peptides play pivotal roles in regulating angiogenesis,
vasculogenesis, and tissue regeneration. Although wild-type ADM and CGRP improve wound healing in a
variety of injury models, they are poor drug candidates for the chronic treatment of different disorders. Our
recent study of super-agonistic ADM analogs, which self-assemble to form liquid nanogels in situ, suggested
these analogs are ideal candidates for mitigating tissue damage and accelerating wound healing in patients
with bed sores or nonhealing pressure ulcers. Notably, the self-assembled analog gel has a 100% loading
capacity and allows localized treatment via its multi-faceted regenerative actions. Ideally, the proposed analog
gel therapy would be administered weekly or biweekly subcutaneously in the wound area to improve local
blood circulation and accelerate wound healing. The Specific Aims of this Phase I study include identifying an
ideal analog gel formulation and dose range that promotes vascular bed circulation but avoids an effect on
systemic hemodynamics in aging diabetic mice (Aim 1). Once the ideal analog gel is identified, we will evaluate
whether the analog gel treatment correlates with enhanced healing functions in aging mice with hindlimb
ischemia injury or pressure-induced skin ulcers. We will also compare the analog gel with PDGF, the only
FDA-approved growth factor for wound care, thereby completing the lead optimization process.

Public health relevance
Based on human hormones essential for maintaining normal vasculogenesis and vascular integrity, we have developed self-assemble peptide analog gels to reduce ischemic tissue damage and improve local blood supply to traumatic wound areas. To facilitate the development of analog gel therapy, we propose to identify an optimal gel lead and demonstrate its efficacy in two pressure ulcer models. Successful development of this therapy could significantly reduce morbidity and mortality resulting from chronic wounds in pressure ulcer patients.